Potentiation of fluoride toxicity in oral pathogens

PROJECT SUMMARY/ABSTRACT
The problem: Dental caries is the leading health condition worldwide, affecting billions of people and causing
pain, impaired nutrition and social functioning, reduction in work/school productivity, and significant economic
impacts. For the most vulnerable groups, such as children and older adults, and individuals with high caries
risk of all ages, the consequences of this disease – including a reduced quality of life, morbidity and even
mortality – are unacceptable. Because caries is caused by the metabolism of dietary sugars by a cariogenic
biofilm, it is very difficult to control; the widespread consumption of fermentable sugars in modern diets favors
cariogenic species such as Streptococcus mutans and the opportunistic fungi Candida albicans in the dental
biofilm, perpetuating the caries process. Fluoride is the most effective agent for caries control, but it has very
limited antimicrobial effects because most microbes have membrane proteins to expel fluoride and keep
intracellular concentrations at sub-inhibitory levels. Different oral microbial species possess different types of
fluoride exporters; S. mutans and C. albicans employ CLCF and FEX proteins, respectively, while beneficial
oral streptococci use Fluc proteins. This creates an opportunity to specifically target pathogenic oral microbes
to modify species dynamics towards health-associated symbiotic communities in biofilms exposed to sugar and
fluoride. Hypothesis: We hypothesize that fluoride export proteins can be targeted for antimicrobial
development against cariogenic oral bacteria and fungi, while leaving beneficial oral microbiota intact. This
hypothesis will be tested in the following specific aims: S.A.#1: To evaluate the competitive fitness of fluoride
export-deficient strains of S. mutans and C. albicans in mixed-species biofilms under conditions of changing
fluoride and pH; S.A.#2: To identify natural products that potentiate fluoride toxicity for pathogenic oral
microbiota. Significance: The results of these studies will establish groundwork for the development of novel
caries treatments that potentiate the antimicrobial effects of fluoride ion, as well as provide new basic
knowledge about the role of fluoride and microbial fluoride resistance mechanisms in community dynamics of
the oral microbiota.

Public health relevance
PROJECT NARRATIVE Fluoride, the main agent for dental caries control, has limited antimicrobial effect because most microbes express membrane proteins to expel fluoride and keep cytoplasmic concentrations low. The goal of this project is to determine how inhibition of fluoride exporters from cariogenic species Streptococcus mutans and Candida albicans alters the microbial composition of dental biofilms, and identify natural products that could cause fluoride export inhibition. The ultimate goal is to potentiate the anticaries effect of fluoride in over-the-counter products like toothpastes and mouth rinses.